Brain Structure/Function In Developmental Neuropsych Dis

Many neuropsychiatric disorders of childhood may reflect subtle deviations in brain development. By acquiring and analyzing MRI images from several clinical groups and healthy controls in an identical fashion we have been able to address important issues of specificity. In the process of providing valid control subjects we have acquired one of the world's largest cerebral MRI data sets of well-screened healthy children and adolescents. The enormous variability of brain structure size highlights the need for large samples and longitudinal study designs, which are underway. Sexually dimorphic patterns of normal brain development may shed light on sex differences in age of onset, prevalence, and symptomatology noted in most childhood neuropsychiatric disorders. For instance, the relatively larger size of the caudate nucleus in females may be related to the male-greater-than-female prevalence of ADHD and Tourette's disorder, which are both associated with decreased basal ganglia size. The smaller gray matter volume in patients with Kleinfelter's Syndrome (XXY) suggests a role of the X chromosome in brain cortical development. Our new image analysis technique now allows us to segment white matter, gray matter, and cerebral spinal fluid on brain MR images and reveals a robust increase with age in white matter, but not gray matter, for our age range of 4 to 18 years. A collaboration with the Montreal Neuropsychiatric Institute to automate quanitifcation of several brain structures and cortical regions is underway. A collaboration with UCLA is permitting detailed anatomic mapping of cortical development.